Investigating and targeting NSD2 mutation-driven leukemia transformation

PROJECT SUMMARY/ABSTRACT
Acute lymphoblastic leukemia (ALL) is the most common childhood cancer and remains a leading cause of
cancer-related mortality, particularly due to relapse. Mutations in NSD2 (also called WHSC1 and MMSET), a
histone methyltransferase, are frequently found in relapsed B-cell ALL (B-ALL), especially in cases with the
ETV6::RUNX1 fusion gene. The heterozygous p.E1099K point mutation is the most prevalent NSD2 mutation
and leads to increased H3K36me2 and decreased H3K27me3. These mutations alter chromatin structure,
disrupting gene expression and driving processes such as glucocorticoid resistance and central nervous system
infiltration. However, how NSD2 mutations initiate leukemia transformation remains unclear. We hypothesize
that NSD2-driven changes in histone modifications alter gene transcription in B cells, leading to leukemia
transformation. To address this, we generated a novel conditional NSD2 p.E1099K mutation knock-in mouse
model and demonstrated that NSD2 mutations alone can drive B-cell leukemia. This project will further
investigate how NSD2 mutations in hematopoietic stem cells promote lymphocyte transformation and explore
their role in the context of the ETV6::RUNX1 fusion gene, which is associated with the most common childhood
ALL subtype. We will employ cutting-edge techniques such as single-cell RNA sequencing (scRNA-Seq), ATAC-
Seq, and CUT&RUN to analyze epigenetic and transcriptional changes caused by NSD2 mutations. Finally, we
will evaluate a novel NSD2 inhibitor in both mouse models and human cell line-derived xenograft (CDX) and
patient-derived xenograft (PDX) models as a potential treatment for relapsed ALL. The specific aims are: 1)
Determine the mechanisms by which NSD2 mutations drive leukemia transformation; 2) Evaluate the role of
NSD2 mutations in driving ETV6::RUNX1 leukemia transformation; 3) Target NSD2 mutation-driven leukemia
transformation. The outcomes of this research will provide a comprehensive understanding of how NSD2
mutations contribute to leukemia transformation and may lead to the development of new therapeutic strategies.
The novel NSD2 inhibitor holds promise for treating NSD2-mutant ALL, offering potential improvements in
survival for relapsed patients. Our mouse models also provide an important platform for further research and
therapeutic testing in blood cancers.

Public health relevance
PROJECT NARRATIVE Despite advances in therapy, acute lymphoblastic leukemia (ALL) remains a leading cause of cancer-related mortality in children. NSD2 mutations are frequently identified in relapsed ALL, particularly in cases with the ETV6::RUNX1 fusion gene, suggesting a role in driving leukemia transformation. This study aims to elucidate how NSD2 mutations contribute to leukemia initiation and progression and develop novel targeted therapies to improve outcomes and survival rates in relapsed ALL patients.